Modification of Troponin T to Improve Cardiac Function in Heart Failure

Project Title: Modification of Troponin T to Improve Cardiac Function in Heart Failure Project Summary Cardiac muscle contraction is regulated via the troponin complex in sarcomeric thin filaments. Troponin consists of three protein subunits: troponin C (TnC), troponin I (TnI), and troponin T (TnT). A restrictive cleavage that selectively removes the N-­terminal variable region of cardiac TnT (cTnT) naturally occurs as an adaptation to myocardial energetic crisis such as ischemia or pressure overload. The N-­terminal truncated cTnT (cTnT-­ND) remains in the cardiac myofilaments with altered functionality to physiologically tune down left ventricular systolic velocity, which elongates the phase of rapid ejection, thereby increasing stroke volume and improving the energetic efficiency of the heart. The proposed research will characterize the mechanism by which cTnT-­ND alters the kinetics of myofilament activity to allow the heart to physiologically compensate for energetic crisis, and will ultimately lay groundwork for the development of new targeted treatments for heart failure. Three Specific Aims are proposed: Aim I is to characterize how the deletion of the N-­terminal variable region of cTnT restores a repressed TnI-­like C-­terminal conformation to result in a conditional inhibition of myofilament ATPase and contractile kinetics. Aim II is to assess the effectiveness of cTnT-­ND on compensating for cardiac dysfunction and improving cardiac efficiency in heart failure mouse models with in vivo and ex vivo functional studies. Aim III is to assess the long-­term effects of cTnT-­ND on cardiac function, reserve and remodeling in normal and failing mouse hearts for translation to new treatments for heart failure. Significance: Heart failure is a major challenge in the management of cardiovascular diseases. While b?-­adrenergic blockade has proven to be clinically effective in treating chronic congestive heart failure, the long-­term benefit of decreasing contractile kinetics remains incompletely understood. The restrictive deletion of the N-­terminal segment of cTnT naturally occurs during myocardial ischemia and pressure overload as a posttranslational regulation to selectively tune down contractile velocity of cardiac muscle and elongate the rapid ejection phase to increase stroke volume and cardiac efficiency. This mechanism provides a novel and specifically targeted approach to sustain baseline cardiac function during energetic crisis and heart failure. Using multi-­level and integrative approaches, our study will lay the groundwork for translating this molecular mechanism into a new clinical treatment for heart failure.

Public health relevance
Project Title: Modification of Troponin T to Improve Cardiac Function in Heart Failure Project Narrative Cardiac troponin T is a subunit of the troponin complex that regulates cardiac muscle contraction. A restrictive proteolytic truncation that selectively removes the N- terminal variable region of cardiac troponin T occurs as a physiological adaptation to sustain heart function in stress conditions. This mechanism provides a novel sub- molecular target for improving cardiac function and energetic efficiency. Using integrative research approaches, our study will establish the underlying mechanism for this physiological modification of cardiac troponin T, with the goal of ultimately developing a new approach for the treatment of heart failure.